Cancer Center Administration

ADMINISTRATION
PROJECT SUMMARY/ABSTRACT
The administrative unit of the Case Comprehensive Cancer Center (Case CCC) is responsible for the organizational support and fiscal oversight of all cancer research-related activities based at Case Western Reserve University (CWRU) and its consortium institutions, University Hospitals (UH) and Cleveland Clinic (CC). The multidisciplinary and translational emphasis of the cancer program is facilitated and supported by a strong and experienced administrative team, with a dedicated staff of 28 under the leadership of John Pounardjian, Associate Vice President and Associate Director for Administration. Case CCC administration directly serves 288 total members from 8 schools across 46 academic departments and divisions. Administration directly manages over $40M in annual research and operating funds and $11M in philanthropic funds supporting the cancer research program. Pounardjian meets regularly with administrators at UH and CC, ensuring cancer research administrative interaction across the consortium institutions, and coordinating processes and regular reporting of research related information. The Specific Aims of Case CCC administration are to:
1. Facilitate the mission and Strategic Plan of the Case CCC.
2. Promote collaborative and innovative cancer research.
3. Be effective stewards of Case CCC financial resources and comply fully with Cancer Center Support Grant (CCSG) requirements.
Case CCC administration implements strategic priorities; oversees and monitors Case CCC activities; promotes multidisciplinary research by providing direct administrative support of programmatic activities; and provides administrative support to advance the goals of Community Outreach & Engagement (COE) and Cancer Research Training and Education Coordination (CRTEC). Administration ensures regular and active communication with members. It sends out weekly newsletters and special announcements that communicate opportunities for funding and scientific interactions, key updates from the consortium institutions, and important national updates. Aligned with the Case CCC strategic plan, administration facilitates and manages multi-investigator grant applications, supports cancer research training across the consortium, fully manages and implements conferences and symposiums, and creates inter-institutional links that add value by enabling communication among Case CCC members and providing seamless administrative support. Since the previous P30 competitive renewal, the Case CCC consortium has continued to evolve with leadership changes and scientific programmatic realignments requiring coordinated support from the administrative team.